Skeletal Biology and Biomechanics (SBB) Core

The UCSF Core Center for Musculoskeletal Biology and Medicine Skeletal Biology and Biomechanics
(SBB) Core supports a large and robust research base of investigators. This diverse group of basic and clinical
investigators has made major contributions to the understanding of musculoskeletal health and disease.
However, the ongoing research efforts by these and other investigators remain insufficient to prevent the rapidly
increasing occurrence of many acquired musculoskeletal diseases in our aging population. Thus, acceleration
of research that advances the prevention and treatment of skeletal diseases is urgently needed. Solutions will
require a more systems-based approach with integrated research strategies and investigator communities. To
meet this challenge, the SBB Core facilitates musculoskeletal research at UCSF by providing integrated, cost-
effective, and efficient access to rigorous musculoskeletal biology and biomechanics services. The SBB Core
serves and cultivates the musculoskeletal research community across multiple campuses and disciplines by
offering users seamless access to services, with Core sites at the two main campuses, easy digital conferencing,
and events at multiple locations. The successful implementation of the SBB Core is anticipated to not only
reduce research expenses and increase the output and quality of data, but also to produce robust in-depth
analyses of samples and animal models through integration of different aspects of musculoskeletal biology and
biomechanics. The Core’s adoption of sophisticated and powerful new services will streamline quantitative
analyses of musculoskeletal tissues to complement and encourage the much-needed application of big data
approaches to this field. Through training and education, the SBB Core will promote the entry of new
investigators to the field and will foster a community of versatile musculoskeletal researchers with a broad set of
skills and critical thinking.

Public health relevance
PROJECT NARRATIVE Not Applicable